From Structures to Affinities: Harnessing Hydration-centric Molecular Simulations for Modulating Protein Interactions

Project Summary
The quest for modulators of protein interactions is undergoing a renaissance with advent of powerful computa-
tional methods for the prediction and de novo design of protein structures. However, translating this static struc-
tural information into an accurate prediction of the thermodynamics and kinetics of dynamic protein interactions
remains a challenge, limiting our ability to robustly design tight-binding modulators of protein interactions. The
limitations of existing structure-based drug design approaches can be traced back to their accounting of collective
hydration effects using additive approximations, such as hydropathy scales, and their tendency to adopt a static
perspective, assuming a relatively rigid protein. Thus, there is a critical need for developing novel computational
methods capable of accurately accounting for the collective reorganization of the hydrogen bonding network of
water as well as any conformational changes that accompany binding. To address this critical knowledge gap, the
proposed program seeks to develop novel hydration-based, enhanced-sampling molecular simulation techniques
for characterizing the reorganization of water structure in response to conformational change and binding, and
to use such a characterization for informing the thermodynamics and kinetics of protein interactions as well as
designing interaction modulators. These techniques will be developed within the context of three judiciously cho-
sen projects spanning a diversity of protein interactions: (i) interactions between reader proteins and methylated
histone tails, (ii) interactions between galectins and carbohydrates, and (iii) interactions between the p38! MAP
kinase and single-domain antibodies. For each project, close interactions with experimental collaborators will
facilitate the reﬁnement of our methods and the validation of our predictions, enabling us to uncover the molec-
ular underpinnings of speciﬁcity. By developing novel computational methods to bridge the gap from protein
structures to afﬁnities, and leveraging these methods to characterize the interactions of proteins with peptides,
carbohydrates, and other proteins, the proposed program thus seeks to transform our ability to predict, under-
stand and modulate protein interactions.

Public health relevance
Project Narrative The interactions of proteins with peptides, carbohydrates and other proteins play an important role in diverse cellular processes and pathologies. Although the advent of powerful computational methods for predicting and designing novel protein structures offer promise in the quest for therapeutic modulators of protein interactions, translating structural information into an accurate prediction of binding afﬁnities remains a challenge. In this work, we seek to use specialized molecular simulations to accelerate the sampling of protein hydration for predicting and modulating protein interactions.